Mindfulness-Based Coping Program for Adolescents

Abstract The purpose of this grant proposal is to create and evaluate the feasibility of a mindfulness-based coping program for adolescents in high school. Many adolescents experience school-related stress on a daily basis, especially those students making the transition from middle school to high school. Because some high school students lack the necessary coping skills to effectively deal with stress, they are in need of new ways to manage their daily lives. Mindfulness training is one possible avenue to build youth's coping repertoires. Emerging research in mindfulness with youth has revealed a range of benefits including improvements in self-regulatory abilities and effective stress responses and decreases in anxiety and externalizing behaviors. Training in mindfulness may provide adolescents with new ways to cope with stress, thereby preventing the development of future health illnesses and diseases. However, no evidence-based programs currently exist that utilize mindfulness as a tool to teach adolescents effective coping skills that may later reduce their stress, as well as physical health problems related to stress. Therefore, the aim of the proposed project is to begin to fill this gap by developing and determining the feasibility of a universal, innovative, developmentally-appropriate, evidence-based mindfulness program for use with high school students. The program will educate the students daily about the impact of stress on the mind and body, as well as new ways to cope with everyday stressors. As part of the mindfulness coping program, adolescents will participate in teacher-led activities focused on the foundations of mindfulness and these activities will be comprised of mindful breathing, mindful movements, and mindful journeys. Additionally, adolescents will learn how to apply the mindfulness skills to their everyday lives, as well as how academic and social stressors may negatively influence their bodies and mind. Students will also be able to access online resources via the program's website to continue their daily practice at home. In Phase I of the project, the program will be developed with input from mindfulness, yoga, stress and coping, adolescent health, as well as technical (e.g., e-learning) and high school teacher consultants. High school teachers and students will participate in separate focus groups to preview the lessons and provide feedback on the program. Then, a feasibility study of the revised and finalized program will be conducted in six high school classrooms (3 intervention and 3 wait-list control) to evaluate the feasibility of the procedures and program. Teachers' and students' responses to pre- and post-test questionnaires and input on the feasibility of the program will be obtained. Pending Phase I results, Phase II will involve completion of the program and website; creation of a mobile messaging system to provide mobile health messages specific to mindfulness to youth participating in the program; development and evaluation of online booster sessions (3 months follow- up to program); design and implementation of a full-scale RCT to evaluate the effectiveness of the mindfulness- based coping program.

Public health relevance
PROJECT NARRATIVE Mindfulness-based programs for youth have been found to be associated with reductions in stress, anxiety, and depression and increases in self-regulation and attention. The purpose of this project is to (1) develop the prototype for a mindfulness-based coping program for high school students and (2) evaluate the feasibility of the program. The proposed program will be designed as an easy-to use, attractive, research-based mindfulness program to be taught by high school teachers to their students that utilizes innovative and engaging multimedia and online resources. This project will result in the development of a commercially available, empirically-tested educational tool that can be used in high school settings. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS Adolescents feel both overwhelmed and anxious (Skrove et al., 2013; Twenge, 2011) and, in fact, they experience anxiety levels higher than reported by same-aged youth decades ago (Twenge, 2000; 2011). School-related problems were rated as the most stressful problems by adolescents (Persike & Seiffge-Krenke, 2012). Adolescents making the transition from middle to high school may be especially vulnerable to stress and anxiety because shifting to an unpredictable and unfamiliar context may be challenging and stressful for some youth (Benner, 2011; Cohen & Smerdon, 2009). Not all high school freshmen make the transition successfully; in fact, the first year of high school is often met with decreases in grades and school engagement and increases in anxiety and loneliness (Benner, 2011; Benner & Graham, 2009; Isakson & Jarvis, 1999; McIntosh et al, 2008). Compounding this is that many adolescents lack the coping skills and resources needed to effectively deal with stress, which can take a toll on adolescents' physical and mental well-being and put them at risk for poor decision-making (Compas, Conner-Smith, Saltzman, Thomsen, & Wadsworth, 2001; Galvan & Rahdar, 2013; Twenge, 2000). Adolescents starting high school need to develop a repertoire of effective coping strategies that can be used daily to reduce their reactivity to stress as well as the number of physical health problems associated with exposure to stress (e.g., headaches, stomachaches, insomnia). The development and utilization of daily mindfulness practices provides an effective method for building coping skills in youth. Thus, there is a critical need for a new universal prevention program that will help new high school students learn and utilize mindfulness skills that will help them to manage the myriad academic and social stressors encountered in their everyday lives and forms the primary goal of the proposed product. Mindfulness has been conceptualized as being attentive to and aware of what is taking place in the present moment and accepting each moment without judgment (Kabat-Zinn 1994; 2003). Emerging has revealed a range of key benefits for mindfulness training with youth including increases in attention, behavior and emotion regulation, effective stress responses, and social-emotional competence, as well as decreases in sleep problems, depression, anxiety, and externalizing behaviors (Biegel et al., 2009; Bootzin & Stevens, 2005; Broderick & Metz, 2009; Mendelson et al., 2010; Saltzman & Goldin, 2008; Schonert-Reichl & Lawlor, 2010). In addition, being mindful during adolescence is associated with lower rates of unhealthy behaviors (e.g., smoking; Black et al., 2012). Mindfulness training can provide adolescents with new ways to cope with stress, thereby preventing the development of future health problems (McCabe Ruff & Mackenzie, 2009). Of the evidence-based prevention programs that exist for adolescents (http://www.nrepp.samhsa.gov/), none focus on the transition to high school or stress as a main outcome. In addition, despite the many benefits of mindfulness for youth's physical and mental health, there is a lack of innovative and effective evidence-based mindfulness programs designed for high school students currently available. Of the two mindfulness-based programs that exist, one is specifically designed for treatment with an adolescent psychiatric outpatient population (Biegel et al., 2009) and the other program focuses on emotion regulation as part of mindfulness training and its findings are based on only female high school students (Learning2Breathe, Broderick & Metz, 2009). In contrast, the proposed program will be designed for adolescents, particularly those who are making the transition to high school, and will educate adolescents daily (for a four week period) about the impact of stress on the mind and body, as well as new ways to cope with everyday academic and social stressors. Thus, the proposed project will fill a void in the coping and contemplative education fields. The results of this Phase I project would make a substantial and sustained impact on the field of adolescent stress and coping, as well as mindfulness and contemplative education. Because most coping programs are created for elementary and middle schools, the prevention field would benefit from the creation of an effective, evidence-based program that targets effective methods to help adolescents cope with everyday stress, particularly for students starting their high school careers. Additionally, the program would create a contemplative educational program focusing on positive youth development. Given that empirical work supports the link between mindfulness and stress and coping in youth, the proposed program will be the result of applying this basic research to creating a scientifically informed, evidence-based, practically applicable, developmentally-appropriate, marketable product to high schools and community organizations that utilizes state-of-the-art technology in instructional resources for the classroom and online resources for students. The specific aims of this Phase I project are to: 1. Develop a universal mindfulness education program for adolescents; 2. Obtain focus group feedback from high school teachers and students on a prototype of the program; 3. Evaluate the mindfulness program by conducting a feasibility study. Phase II will involve completion of the program and website; creation of a mobile messaging system to provide mobile health messages specific to mindfulness practice to youth participating in the program; development and evaluation of online booster sessions (3 months follow-up); design and implementation of a full-scale RCT to evaluate the effectiveness of the mindfulness education program.